Peripheral Limitations in Pulmonary Hypertension and Effects of Muscle Training

PROJECT SUMMARY/ABSTRACT
Dr. Yogesh Reddy, MBBS, MSc, is an Assistant Professor in the Department of Cardiovascular Medicine at
Mayo Clinic. Dr. Reddy is seeking a Mentored Career Development Award to develop the training required to
study the contribution of skeletal muscle abnormalities to exercise performance in patients with Pulmonary
Arterial Hypertension (PAH). Dr. Reddy has received extensive training in pulmonary vascular hemodynamics
in PAH during his previous training under the T32 grant, providing necessary skills and experience to study the
central cardiovascular abnormalities that drive exercise intolerance in PAH. While therapies targeted to these
central limitations have markedly improved clinical outcomes in PAH, a wide therapeutic gap remains, as nearly
90% of patients report significant residual symptoms even after treatment with pulmonary vasoactive therapy.
Preliminary studies have suggested that peripheral abnormalities in skeletal muscle may contribute to the
exercise intolerance of patients with PAH, but no study has yet used gold standard methods to measure skeletal
muscle oxygen (O2) utilization during exertion in PAH. To fill this knowledge gap and build new skills in the
characterization of peripheral deficits in PAH, Dr. Reddy proposes to: 1) determine the independent role of
skeletal muscle and mitochondrial O2 transport abnormalities in exercise performance in PAH compared to
controls, and 2) perform a randomized clinical trial of isolated quadriceps (knee-extension) based training to
assess its effect on peripheral O2 transport and whole-body exercise performance in PAH. In this proposal, Dr.
Reddy is seeking the primary mentorship of Dr. Barry Borlaug, an experienced, NIH-funded investigator with
expertise in exercise physiology in pulmonary hypertension, who has a proven track record of successfully
mentoring junior investigators. The mentorship team supervised by Dr. Borlaug includes multidisciplinary experts
who will provide necessary advanced training in the fields of mitochondrial biology (Dr. Sreekumaran Nair), leg
blood flow quantification and exercise training interventions (Dr. Thomas Olson), iterative mathematical modeling
and biostatistical methods (Dr. Rickey Carter), patient reported outcomes (Dr. Shannon Dunlay) and clinical trials
in PAH (Dr. Robert Frantz). As a result of the training proposed, Dr. Reddy will obtain the skills necessary to: 1)
comprehensively evaluate mitochondrial and peripheral O2 transfer physiology during exertion, and 2) conduct
randomized trials of an exercise-based intervention. The advanced training obtained during this award in skeletal
muscle biology and exercise physiology will greatly complement the skills he has already obtained characterizing
central hemodynamic abnormalities in PAH, uniquely positioning him to succeed as an independently-funded
clinician scientist focused on the pathophysiology and treatment of exercise intolerance in PAH, understanding
and investigating the problem “from all angles”. The data derived and expertise gained will form the basis for a
competitive R01 application centered on novel treatments targeting peripheral deficits for patients with PAH.

Public health relevance
PROJECT NARRATIVE: Pulmonary arterial hypertension (PAH) is a debilitating condition that often affects people in the prime of life resulting in right heart failure with severe impairments in quality of life and exercise capacity. In this project, we will directly measure peripheral oxygen (O2) utilization at the skeletal muscle and mitochondrial level during exertion in people with PAH for the first time, and then conduct a randomized clinical trial of leg-muscle focused exercise training to improve muscle O2 utilization and exercise capacity. As a result of this work, we will be able to determine the mechanisms and independent role of skeletal muscle abnormalities in PAH related symptoms, as well as their ability to respond to a novel and easy to implement leg-muscle exercise program.